Methods for Fast and Efficient Oxygen Imaging

Abstract
Intermittent or acute/cyclic hypoxia in tumors, with frequencies between a few cycles per minute to hours, is
receiving increased attention because this type of hypoxia has been reported to have an influence on tumor
malignancy as well as treatment resistance via increased expression of pro-survival pathways. Fast oxygen
imaging methods are needed for the measurement of acute tumor hypoxia. Pulse electron paramagnetic
resonance imaging (pEPRI) is a promising tool to provide three-dimensional partial oxygen pressure (pO2) maps
in live tissues and tumors to assist with advanced studies of tumor biology, perfusion, drug development, and
radiation treatment. Single point imaging (SPI), an acquisition technique developed at National Cancer Institute
(NCI), is a subset of pEPRI methods that can be used for oxygen image acquisition. It provides high-resolution,
high-fidelity images but is slow due to the need for acquiring each k-space point individually. In the current
project, our goal is to improve the image acquisition speed of SPI by utilizing a combination of advanced
hardware and deep learning. This will improve the imaging speed by many folds without compromising the
image quality. These advances will be tested in a mouse model of fibrosarcoma tumor. This project will bring an
NIH-developed technology to the commercial level. Our long-term goal is to imply the advanced hardware and
software technologies of oxygen imaging to clinics to assist with oxygen-guided tumor treatments.

Public health relevance
Narrative Cyclic hypoxia, with frequencies between a few cycles per minute to hours, is receiving increased attention because of its influence on tumor malignancy and treatment resistance. Fast tumor oxygen imaging methods are needed for the measurement of acute hypoxia. This project will apply advanced hardware and deep learning technologies to single point imaging, a pulse electron paramagnetic resonance oxygen imaging method, to acquire fast oxygen maps in tumors.